Health Education through Arts-based Learning (HEAL): A Partnership to Investigate Interdisciplinary Science Programs in Rural Communities

Project Summary/Abstract
Biomedical science and science professions can seem unattainable to many low-income and minority children
living in rural-agricultural regions across the United States. There is a need for educational programs and rural
capacity building initiatives that will help these children see themselves and their rural communities as a
genuine part of the biomedical enterprise. To address this need, this project will establish the Health-sciences
Education through Arts-based Learning (HEAL) partnership; an interdisciplinary collaboration of Washington
State University biomedical science and Science, Technology, Engineering, Mathematics, and Medicine
(STEMM) education researchers, rural education partner organizations, practitioner partners, and community
stakeholders from low-income, ethnically diverse communities in rural-agricultural Central Washington. The
long-term goal of this project is to bolster the recruitment of students from these underrepresented
communities into the biomedical research pipeline. To pursue this goal, the project's overall objective is to
foster early interest in, understanding of, and appreciation for STEMM and biomedical science career
possibilities among low-income and ethnically diverse rural children in grades 3-5. Situated at the cutting edge
of research on systems-level thinking and arts-integrated STEMM learning, HEAL will develop a
comprehensive educational program and cohort of well-prepared community educators to foster creative,
visual learning about complex zoonotic diseases systems, such as West Nile Virus and enteric bacteria, and the
impact of these diseases on rural-agricultural communities. The project will pursue two specific aims: 1)
Design an equitable, effective, and comprehensive arts-based health science education program about disease
systems in rural-agricultural regions; 2) Build educator capacity in rural-agricultural regions through
professional development in arts-based health science education. Under the first aim, HEAL will develop and
implement four curriculum modules, public youth-exhibition community events, and portable arts-integrated
biomedical science activity kits to be used in rural libraries, community centers, clinics, and schools. Under the
second aim, HEAL will build comprehensive, sustained professional development programs, including
intensive year-long courses, three-day regional workshops, and online training materials for national-level
distribution, for elementary-level educators and other adults serving the target communities. HEAL's approach
is innovative because it uses systems-level thinking as a tool for advancing equity in biomedical fields, equips
underrepresented children with visual and spatial artistic tools to learn and communicate biomedical science
across language divides, and challenges the status quo of rural education capacity building by developing
expertise from within underserved communities. This project is significant because it will advance biomedical
science education for underserved and increasingly diverse rural-agricultural communities across the US,
ultimately strengthening and diversifying the biomedical workforce.

Public health relevance
Project Narrative The HEAL project is relevant to public health because it is expected to increase the number and diversity of students from rural Washington entering biomedical careers by fostering early engagement and understanding of Science, Technology, Engineering, Mathematics, and Medicine (STEMM) in underrepresented populations. In addition, the project's capacity building and public engagement initiatives are expected to bolster health literacy in both Hispanic and non-Hispanic students living in rural-agricultural communities. Thus, the proposed project advances the mission of NIH National Institute of General Medical Sciences by providing educational activities that bolster the development of the nation's biomedical, behavioral, and clinical research workforce.